THE PURPOSE OF THIS TASK ORDER IS TO PRODUCE ONE BATCH OF 10,000 ENDOXIFEN CAPSULES, 40 MG PER CAPSULE. (POP: 01/30/2020 TO 06/29/2020)

Production of a batch of ten thousand of Z-Endoxifen 40mg hard gelatin capsules.